NorCal-RCC for Northern California Regional Coordinating Center

Systematic study of methods to prevent, treat, and recover patients with stroke is essential to reduce the
societal burden of this significant disease. Multi-center trials are essential to accrue significant numbers of
patients to practically complete such research. Using a consortia model whereby multiple centers are
continually initiating multicenter trials and enrolling patients allows for more efficient use of resources and
higher enrollment rates in shorter time. The NIH StrokeNet has made this model a reality with UCSF (NorCal-
RCC; RCC-13) as one of 25 Regional Coordinating Centers (RCCs). NorCal-RCC was created by UCSF
pairing with Kaiser Permanente Northern California (KPNC) to access brain-trusts of stroke researchers
and the existing infrastructure for multi-center clinical trials. NorCal-RCC now includes 14 sites including 5
KPNC sites across the region, with a combination of academic and community sites across a range of diverse
patient populations. In addition, our Stroke Fellowship continues to train leaders in stroke research with
the majority continuing in academic stroke related endeavors. This RCC brings stroke research to a diverse
population where non-Hispanic whites now comprise only a simple majority at 50% and with Latino and Asian
Pacific Islander populations that are growing. We recently added Queen's Medical Center in Oahu, Hawaii to
access a key population Asian Pacific Islander community. NorCal-RCC will continue to serve as a top
enrolling site with excellent data quality, to provide new important study ideas and contributions to the
network as a whole, and to provide top level fellowship training to the next generation of stroke
academicians.

Public health relevance
NorCal-RCC is one of 25 Regional Coordinating Centers (RCC-13) study of prevention, treatment, and recovery of human stroke with NIH StrokeNet. Continued funding of this important infrastructure will allow another 5 years of high enrollment rates and high quality data for clinical trials performed in the network. NorCal-RCC has the potential to bring stroke research to a large section of diverse and underserved people who are specifically at risk for stroke.